Neural Mechanisms Underlying Cataplexy Control by MCH Neurons

PROJECT SUMMARY
Understanding the neural mechanisms underlying narcolepsy with cataplexy (NC) is crucial, considering the
debilitating and life-threatening nature of this sleep disorder and its high prevalence. Previous studies have
established that the loss of orexins is the fundamental cause of NC in humans and animals. However, the role
of melanin-concentrating hormone (MCH) neurons, which are reciprocally connected with orexin neurons and
play a complementary role in sleep-wake regulation, in the pathophysiology of NC remains unclear. The
proposed work is aimed to address this question and to define the neural circuitry through which MCH neurons
may influence cataplexy. To understand if MCH neurons are active during cataplexy, in Aim1, we will image
activity dynamics of MCH neurons in a mouse model of NC during spontaneous cataplexy as well as in the
presence of positive emotional stimuli that enhance cataplexy. To demonstrate a causal role of MCH neurons
in cataplexy, in Aim 2, we will selectively activate and silence the MCH neurons using chemogenetic methods
and study the changes in spontaneous cataplexy and positive-emotion-triggered cataplexy (PES-cataplexy).
As MCH neurons heavily project to the midbrain locomotor region (MLR; involved in facilitating muscle tone
and locomotor activity), whose lesions in rats produced cataplexy, we then hypothesized that the MCH neurons
might target the MLR to modulate cataplexy. We will test this hypothesis, in Aim 3, by studying the changes in
cataplexy a) following in vivo optogenetic stimulation of the MCH terminals in the MLR with concurrent
chemogenetic inhibition of MCH soma and b) following optogenetic inhibition of the MCH terminals in the MLR
with concurrent chemogenetic activation of MCH soma. Finally, in Aim 4, to identify the neurochemically
distinct subset(s) of MLR neurons involved in MCH control of cataplexy, we will chemogenetically activate or
inhibit the glutamatergic and GABAergic neurons in the MLR in mice with or without orexins and study
cataplexy behavior. Collectively, these experiments will identify the specific mechanisms and pathways by
which MCH neurons influence cataplexy and thereby will improve our understanding of the neural basis of NC.

Public health relevance
PROJECT NARRATIVE Narcolepsy with cataplexy is a chronic debilitating sleep-wake disorder affecting over 3 million people worldwide. This project is aimed to understand the neural mechanisms contributing to the pathophysiology of this disorder using animal models. Thus, the outcomes of this proposal will undoubtedly improve our knowledge on the neurological basis of narcolepsy with cataplexy and will aid in the development of better prognostic, diagnostic and therapeutic options for this disorder.